The Role of MYC Mutations in acute Myeloid Leukemia

Project Summary
This proposal outlines a 5-year research and career development plan designed to support the candidate’s
trajectory towards an independent academic career. The proposed research project, which focuses on acute
myeloid leukemia (AML)-associated MYC mutations and their key target genes in AML cells, will capitalize
on critical expertise and resources available at Washington University School of Medicine. The career
development plan and didactic work will provide the candidate with a variety of skills that will enable a successful
transition to independence. This proposal is founded on our recent observation that a unique set of recurrent
MYC missense mutations are significantly enriched in the dominant clones of normal karyotype AML patients
who have very long first remissions (>5 years) with chemotherapy only; in our series, 6/6 MYC mutations co-
occurred with NPM1 mutations (NPMc), suggesting a unique form of cooperativity. Based on our preliminary
findings, we hypothesize that: 1) AMLs overexpressing WT or mutant MYC proteins are biologically different; 2)
each MYC mutation may have unique effects on its transcriptional targets; and 3) MYC mutations may cooperate
with NPMc mutations. To address these hypotheses, we propose the following specific aims:
Specific Aim 1: We will examine the function of AML-associated MYC mutations alone, or in cooperation
with NPMc. We have developed a doxycycline-inducible system that allows us to regulate Myc expression in
hematopoietic stem and progenitor cells (HSPCs) that do or do not contain the Npmc mutation. Using this
system, we will evaluate how WT or mutant Myc, with or without Npmc, impacts AML development, progression,
and AraC responsiveness both in vitro and in vivo. We are also developing a more physiologic, conditional
knock-in model of MYCT58N (a recurrent mutation both in AML and B cell malignancies) that will allow us to
explore the influence of physiologic doses of mutant Myc and Npmc on AML pathogenesis and AraC sensitivity.
Specific Aim 2: We will define the transcriptional outputs and genomic binding sites of WT vs. mutant
Myc proteins in AMLs arising in WT vs. Npmc mice. To identify Myc dysregulated genes, we will use scRNA-
seq to determine the transcriptional profiles of AMLs (obtained in Aim 1) initiated by WT vs. mutant Myc over-
expression, either alone or in combination with Npmc. We will also perform ChIP-seq studies to characterize the
genomic binding sites of WT vs. mutant Myc, and perform an integrated analysis of these datasets to define the
relative contributions of direct vs. indirect effects of Myc on transcriptional outputs in AML cells. By combining
the results of the functional studies (Aim 1) with the expression and DNA binding studies (Aim 2), we hope to
better understand how Myc mutations alter transcription in hematopoietic cells, and how Npmc affects this output.
If these studies are successful, they may provide important insights on MYC-mediated transformation, refine our
current predictive tools for AML risk stratification, identify pathways involved in AraC sensitivity, and allow us to
create new approaches for the treatment of AML patients.

Public health relevance
Project narrative Currently, the factors that determine the effectiveness of chemotherapy for AML are poorly understood. We recently discovered that some Normal Karyotype AML patients, who had very long first remissions with chemotherapy alone, had unexpectedly high frequency of pathogenic MYC mutations in the dominant leukemia clone at diagnosis. In this proposal, we will systematically explore the molecular mechanisms by which AML- specific MYC mutations sustain leukemogenesis and increase the AraC sensitivity of AML cells, which may lead to new approaches for risk stratification, and novel approaches for therapy.